Regulatory Role of ILC2 in Acute Lung Injury in Sepsis

Severe sepsis complicated with multiple organ dysfunction syndrome (MODS) is a leading cause of death in
ICU. Acute lung injury (ALI) is an important component of MODS and often serves as a direct cause of death.
Nonetheless, few effective therapeutic targets for ALI have been identified. Our long-term goal is to determine
the mechanisms by which sepsis promote ALI, thereby potentially identifying novel targets for prophylactic
intervention. Innate lymphoid cells (ILCs), a new member of the lymphoid population, play a central role in
innate immunity of host response to inflammation, infection, and tissue damage. ILCs are composed of three
subgroups, ILC1, ILC2, and ILC3. ILC2 are a main ILC subtype in the lungs in both human and mouse, and
play an important role in maintaining airway barrier integrity and lung tissue homeostasis. However, the role of
ILC2 in sepsis-induced ALI remains unclear. This research project aims to understand the regulatory role of
ILC2 in the development and progression of ALI and the mechanism underlying ILC2 mobilization, migration,
and expansion in the lung in sepsis through three Specific Aims (SA): SA1. To determine the role of ILC2 in the
progression of ALI following sepsis; SA2 To determine the mechanism underlying ILC2 mobilization from BM
and migration into the lung in sepsis; and SA3 To determine the mechanism of ILC2 expansion in the lung in
sepsis. The results of the study will serve as essential foundation for potential novel treatment of ALI in sepsis
by regulating ILC2 migration, expansion, and function.

Public health relevance
Acute lung injury (ALI) is a major component of multiple organ dysfunction syndrome (MODS) following sepsis; however, few specific targets have yet been identified that predispose septic patients to MODS and ALI, rendering mortality rates high and effective treatment lacking. Innate lymphoid cells (ILCs) are a new member of the lymphoid population playing important roles in host response to inflammation and infection. Group 2 ILCs (ILC2) are a main ILC subtype in the lungs. Gaining insight into the regulatory role of ILC2 in ALI and the mechanism of ILC2 mobilization, migration, and expansion in the lungs in sepsis will provide us with novel targets for preventive and therapeutic interventions for ALI in septic patients. Furthermore, in a broader sense, the proposed studies will contribute to a greater understanding of the pathogenesis of a number of human diseases in which innate immune cells are involved in the inflammatory process.